Prolonged duration and triggered local anesthesia

Pain is a very common clinical problem, causing suffering in millions of people. Treatment of pain that lasts
longer than a brief procedure can be difficult and can entail the use of opioids, with their side effects and
potential for addiction and diversion. In this research we seek to develop injectable drug delivery systems
(DDS) using sustained release technology to provide continuous prolonged duration local anesthesia (PDLA)
lasting many hours to days for perioperative pain, or even weeks for chronic pain. In addition, we are
developing DDS where the patient could determine when she or he receives local anesthesia, how intense the
anesthesia is, and how long it lasts. Those on-demand DDS (termed triggered local anesthetics) are controlled
by external energy sources such as near-infrared light and ultrasound. Both the continuous and triggered DDS
have the potential to revolutionize pain management, and advance the science of drug delivery. They could
also mitigate or obviate opioid use.
All the DDS should ideally: be delivered by a single injection; be easy to administer; not require general
anesthesia or surgery to initiate; last days-weeks; cause no local inflammation, local neuro- or myotoxicity, or
systemic toxicity; be fully biodegradable and reversible; be cost effective, easy to make, and stable.
Triggerable systems should be easy to use with a safe and convenient device.
Our strategy has been to use sustained release vehicles to deliver site 1 sodium channel blockers
(S1SCBs) such as saxitoxin and tetrodotoxin in combination with compounds that are known to enhance their
duration of nerve blockade, such as conventional local anesthetics and steroids. In PDLA, we have achieved a
liposomal formulation containing S1SCBs and other drugs, which can achieve sciatic nerve blocks in the rat
lasting a week with minimal systemic and local toxicity. In triggered local anesthesia, we have produced
liposomes containing S1SCBs and other drugs which produce an initial nerve block that resolves, after which
nerve block can be safely and repeatedly re-induced by targeting the injection site with near-infrared light or
ultrasound. This work produced 31 papers in the past 5 years, many in prominent journals.
In PDLA, we propose a spectrum of potential approaches to produce yet longer blocks while improving
safety. In triggered LA, we propose means to modulate or negate the initial nerve block, extend the number of
triggerable events, and extend the time frame over which they can be triggered – allowing use in chronic pain.
Addressing these challenges will entail overcoming challenges in biomaterials / drug delivery / nanoscience,
including enhancing the loading of highly water-soluble charged drugs in DDS, minimizing their initial rapid
(“burst”) release, extending their duration of release, and /or minimizing their baseline (un-triggered) release.
Importantly, the impact of new approaches on tissue reaction will be studied, using histological and
toxicogenomic approaches.

Public health relevance
Prolonged pain after surgery and chronic pain afflicts millions of people in the U.S. and across the globe. We will develop means of treating such localized pain with a single injection that would last for days to weeks, and systems where that pain relief could be triggered on demand and adjusted to the patient’s needs.